Disruption of Cellular RNA Processing by Kaposi's Sarcoma-Associated Herpesvirus

ABSTRACT
Kaposi sarcoma-associated herpesvirus (KSHV) is the predominant etiologic agent of AIDS-
associated cancers. It is endemic in many areas of Africa where, due to the extraordinarily high HIV burden,
Kaposi sarcoma has emerged as one of the most common cancers. During AIDS-induced
immunosuppression, KSHV replication is no longer effectively controlled, and, together with a large
latently infected population of cells, contributes to disease progression and transmission. During lytic
replication, KSHV dramatically remodels the host gene expression environment. A key player in this
remodeling is the virally encoded, messenger RNA (mRNA) endonuclease termed SOX, which degrades
cytoplasmic mRNA. SOX activity plays diverse roles in the gammaherpesvirus lifecycle and immune
evasion. However, little is known about how the SOX protein is functionally regulated, either by the virus
or by the host cell. Our preliminary data indicate that it is regulated both spatially and kinetically to balance
the need for host shutoff against viral gene expression. In Aim I, we will define how these regulatory
features impact SOX targeting of cellular and viral RNA transcripts throughout the course of KSHV lytic
infection.
SOX-induced cytoplasmic mRNA decay activates a feed forward loop that suppresses cellular but
not viral transcription by RNA polymerase II (Pol II), effectively magnifying the depletion of the cellular
mRNA pool. We previously showed that transcriptional repression requires the nuclear influx of a pool of
cytoplasmic RNA binding proteins, which is triggered by mRNA. Thus, SOX profoundly alters both cellular
RNA stability and synthesis and serves as a model for understanding how pathogenic stress impacts
transcription. In Aim 2, we will define the sub-nuclear changes that underlie transcriptional repression
during lytic KSHV infection, including how specific RNA binding proteins that are relocalized upon mRNA
decay contribute mechanistically to this phenotype. Findings derived from this proposal should have a
sustained impact on the field of gammaherpesvirus biology and reveal how stress or virus-induced
alterations to mRNA stability influence seemingly distal components of the gene regulation circuitry.

Public health relevance
PROJECT NARRATIVE Kaposi’s sarcoma-associated herpesvirus (KSHV) is an emerging Group 1 pathogen and the major cause of cancers in untreated AIDS patients. Successful KSHV replication requires it to control gene expression in the infected cell, including via widespread destruction of protein coding RNAs. This grant is focused on revealing a how the viral nuclease responsible for this process is regulated and how the infected cell senses and responds to message depletion.